Diastolic Heart Failure in HIV-1 infection

Abstract:
Contemporary estimates suggest that more than 40% of people living with chronic HIV-1 infection (PLWH) have
diastolic heart failure (dHF), a harbinger for adverse clinical outcomes including pulmonary abnormalities,
frequent hospitalizations, and sudden death. To date, the molecular causes for dHF in PLWH remain poorly
understood. This paucity of information and a lack of treatment options have prompted the OAR to list “Strategies
to Prevent and Treat HIV-Associated Heart Diseases” as areas of high priority for HIV research. We hypothesize
that that “elevation of the cytotoxic glycolysis metabolite, methylglyoxal (MG) is a primary cause for dHF
development in PLWH.” This elevation in MG is arising from HIV-1 induce upregulation of glycolysis in infected
immunocytes followed by ischemia-induced increase in glycolysis in vascular cells and cardiac myocytes. This
multi-PI project brings together the expertise of Drs. Keshore R. Bidasee (M-PI, heart failure) and Santhi Gorantla
(M-PI, humanized mice and HIV-1 infection) with assistance from Dr. Prasanta Dash (HIV-1 eradication and
cardiovascular complications), to (1) Define pathobiological trajectories of dHF in relation to MG levels in HIV-1
infected Hu-mice with and with ARD treatment; (2) Characterize mechanisms by which MG increases in HIV-I
infected immunocytes and in myocytes, macrophages and vascular cells under with and without ARD and
hypoxia (3) Show that lowering MG will blunt dHF in HIV-infected Hu-mice with and without ARD.
Accomplishments of these aims will not only define a novel link between glycolysis and early-onset dHF in the
setting of HIV-1 infection, but the data could pave the way for the development of urgently needed therapeutics
to mitigate this disease in PLWH.

Public health relevance
Relevance: More than 40% of HIV-1 infected people on anti-retroviral drug (ARD) therapies have early-onset diastolic heart failure (dHF), a harbinger for adverse clinical outcomes including frequent hospitalizations and sudden death. To date, the molecular reasons for the development of dHF remain poorly understood. This multi-PI project brings together the expertise of Drs. Keshore R. Bidasee (cardiovascular diseases including heart failure) and Santhi Gorantla (humanized mice and HIV-1 infection) with assistance from Dr. Prasanta Dash (HIV-1 eradication and cardiovascular complications), to characterize novel link between glycolysis and heart failure in the setting of HIV infection and ARD, paving the way for the development of urgently needed drugs to attenuate dHF in people living with HIV infection.